SOME DETERMINANTS OF SPOKEN WORD RECOGNITION

The proposal focuses on how listeners accommodate variability in the speech signal during spoken word recognition. We focus on two dimensions of systematic variability, co-articulatory information and phonological variation. Phonological variants of a word are hypothesized to be explicitly represented (pre-compiled) in lexical representations and includes a linkage between alternative forms that is excitatory and variant frequency sensitive. Co-articulatory information is investigated with regard to its role in activating and maintaining lexical representations. The goal is to understand how potentially constraining sources of linguistic knowledge (form frequency, acoustic-phonetic similarity and sequential structure) are coordinated with systematic variation to generate and confirm lexical hypotheses.